Replication study of in vivo postnatal gene editing for metabolic liver disease in the nonhuman primate model

PROJECT SUMMARY / ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-RM-
24-009. As part of our NIH Common Fund’s Somatic Cell Genome Editing Program-funded U19 cooperative
agreement (U19NS132301), we are seeking to develop and perform IND-enabling studies with gene-editing
therapies for phenylketonuria (PKU) and hereditary tyrosinemia type 1 (HT1), using lipid nanoparticles (LNPs)
as the delivery method. However, there are currently no clinical-grade LNP formulations available for unrestricted
use by academic investigators. To enable our therapies, we have developed our own LNP formulation comprising
four lipid excipients, a messenger RNA (mRNA) encoding a gene-editing protein, and a guide RNA (gRNA). In
a proof-of-concept preclinical study performed in our internal academic animal facility, we dosed each of four
juvenile cynomolgus monkeys with a single dose of LNPs with an adenine base editor mRNA and a gRNA
targeting the PCSK9 gene, a well-validated gene editing target. Three weeks following treatment, we observed
42-55% whole-liver editing of the PCSK9 gene with concomitant reduction of blood LDL cholesterol—editing
levels compatible with treatment of PKU, HT1, and a variety of other diseases. The LNPs were well tolerated,
with no perturbation of liver function tests (LFTs). We propose to undertake a replication study with our internally
produced LNPs, administered to cynomolgus monkeys by an NIH-selected contract research organization
(CRO), to confirm the robustness of our pilot observations on efficacy and safety. Validation of our LNP
formulation will: (1) provide critical information for IND applications for PKU, HT1, and other diseases; (2) enable
the production of clinical-grade gene-editing therapies for use in our investigator-initiated early-phase clinical
trials; and (3) broadly enable academic investigators to pursue the development of LNP-based gene-editing
therapies by making a non-commercial LNP option available to the scientific community.

Public health relevance
PROJECT NARRATIVE In vivo gene editing via lipid nanoparticle delivery of messenger RNA (mRNA) encoding a gene-editing protein and a guide RNA (gRNA) offers the potential to treat phenylketonuria (PKU), hereditary tyrosinemia type 1 (HT1) and other diseases. However, there are currently no clinical-grade LNP formulations available for unrestricted use by academic investigators. We have developed our own LNP formulation comprising four lipid excipients, an adenine base editor mRNA, and a gRNA targeting the PCSK9 gene which, when delivered to juvenile cynomolgus monkeys, resulted in whole liver editing adequate to treat PKU and HT1 and we will now perform replication studies to validate these findings providing critical information to other academic investigators and for IND applications for PKU, HT1 and other diseases.